GENETIC CONTROL OF ENTRY INTO MEIOSIS IN YEAST

One of the unique features of eukaryotic organisms is the ability to go through meiosis, the process that yields gametes for sexual reproduction. Meiosis is precisely regulated: meiosis is generally restricted to particular tissues, types of cells, or environments. The object of this proposal is to understand how cells of the yeast, Saccharomyces cerevisiae, exit the mitotic cycle and enter meiosis. This decision is determined both by the mating type locus (MAT) and by nutritional signals. Meiosis is restricted to a particular type of cell, the a/alpha cell, that expresses the two MAT alleles, MATa and MATalpha. a/alpha cells enter meiosis only in response to nutritional limitation. The RME1 gene (regulator of meiosis) encodes an inhibitor of meiosis. RME1 is transcriptionally repressed by the combination of one MATa product and one MAT alpha product. Accordingly, repression of RME1 permits a/alpha cells to enter meiosis in response to starvation. The main question now is the mechanism through which RME1 product inhibits meiosis. The answer has three parts: when, in meiosis, RME1 product acts, what the target genes are whose expression or products are inhibited by RME1 protein, and how RME1 protein interacts with its targets to exert inhibition. Present studies address features of the RME1 protein, such as primary sequence, biochemical activities, and subcellular localization. This information will provide clues about RME1 product activity. The specific aims of this proposal are to identify the meiotic events and target genes that are inbitited by RME1 product, to determine how target gene activity is regulated, and to determine the mechanism through which RME1 product governs target gene activity. These studies will be accomplished through approaches of molecular and classical genetics. This work will elucidate the regulation of a fundamental biological process at the molecular level.